MONITORING OF HEART RATE VARIABILITY DURING ALCOHOL WITHDRAWAL SYNDROME

This clinical protocol will examine measures of heart rate variability (HRV) in male and female alcoholics admitted for drinking cessation continuously and non-invasively. These measures will be compared and contrasted with HRV parameters studied in healthy comparison subjects. Inter-beat interval (IBI) will be measured in patients for 3 consecutive 96 hours periods every 7 days during the course of treatment. Coarse-graining spectral analysis (CGSA) will be utilized to simultaneously evaluate parasympathetic (PNS) and sympathetic (SNS) nervous system indicators, and a measure of signal complexity and variability.